The role of ISG15 and ISGylation in the senescence-associated secretory phenotype

Cellular senescence is a cellular state that affects age-related diseases such as inflammation, cancer
development, and cancer progression. Cells that enter senescence have a senescence-associated secretory
phenotype (SASP) that has major, and usually detrimental, effects on other cells in the surrounding
microenvironment. ISG15 is a ubiquitin-like protein that can covalently modify host and pathogenic proteins,
changing their stability and function. ISG15 can also be secreted and function as a cytokine. While ISG15 is
classically regarded as an interferon-stimulated gene that is induced during infection by pathogens, it can also
be upregulated by DNA damage and stress. Recent studies have demonstrated that ISG15 is among the most
upregulated genes across tissues in aging rodents. It has also been shown by us and others that ISG15 is
upregulated during replicative senescence of human fibroblasts. Our preliminary data further indicates that
ISG15 is significantly upregulated in skin fibroblasts derived from patients with dyskeratosis congenita, a human
model of dysfunctional telomerase and shortened telomeres. Immortalization of DC cells by telomerase
activation restores ISG15 levels to normal. Little is known about how ISG15 upregulation contributes to
senescence and what proteins are ISGylated in senescent cells. Further, it is unknown how ISGylation changes
upon cell immortalization. We hypothesize that upregulation of ISG15 and concomitant ISGylation of
proteins caused by DNA damage is important for the SASP. In this proposal, we will determine what the
interplay is between secreted ISG15 and ISGylation in senescence and immortalization. Using our unique patient
cells and cell lines, we will map the senescence-associated ISGylome using innovative proteomic strategies
pioneered in our laboratories. We will compare the ISGylomes between cells that have been induced to senesce
by different mechanisms and from human and mouse, and we will determine how secreted ISG15 affects
surrounding cells. Further, we will assess how immortalization by telomerase or viral oncogenes changes the
ISGylome. Finally, we will specifically determine how ISG15 and ISGylation affects the SASP through genetic
manipulation of cells to have reduced and enhanced ISGylation. These studies will provide key insight into how
upregulation of ISG15 and ISGylation of specific cellular proteins play a role in cellular senescence and, in
particular, the SASP.

Public health relevance
Cellular senescence causes aging-associated conditions such as inflammation, tissue degradation, and cancer through a mechanism that involves secretion of detrimental factors by senescent cells to surrounding cells and tissue. ISG15 is a small protein activated by pathogen infection, DNA damage, and senescence that modifies other proteins to change their stability and function. Our studies will determine how upregulation of ISG15, secretion of ISG15, and modification of specific cellular proteins by ISG15 play roles in causing and maintaining the secretory state of senescent cells, pointing to potential mechanisms to ameloriate aging- associated disease.